Mindful Movement for Physical Activity and Wellbeing in Older Adults: A Community Based Randomized Hybrid Effectiveness-Implementation Study

PROJECT SUMMARY. This renewal application is submitted in response to PA-19-031-Administrative Supplements for Complementary Health Practitioner Research Experience to support a second year of support for Heidi Mendenhall, a Doctor of Chiropractic. Renewal will build upon a productive first year, and continue to provide Dr. Mendenhall an immersive research experience in the parent research study, Mindful Movement for Physical Activity and Wellbeing in Older Adults: A Community Based Randomized Hybrid Effectiveness-Implementation Study (4R33AT009110). Dr. Mendenhall’s career goals continue to be exceptionally well-aligned with the aims and scope of the parent research study which provide unique opportunities for experiential training in community and team-based research. The specific aims of the parent trial include assessing the effectiveness of Mindful Movement (experimental intervention) versus an active control intervention in a randomized study (n=182) as measured by changes in the primary physical activity outcome of time spent per week in ≥10 minute bouts of moderate-vigorous physical activity (MVPA) at 9 weeks (AIM 1). Secondary measures include sedentary activity, steps per day and self-reported quality of life, exercise self-efficacy and expectations, mindfulness, wellbeing, bodily pain, physical activity, social connectedness and assurance, and others, at 9, 26, and 52 weeks (AIM 2). To facilitate interpretation of the RCT results and provide resources for translation and sustainability, contextual information is collected from participants and other stakeholders using mixed methods to explore barriers and facilitators to engagement (AIM 3), especially in underrepresented populations. Dr. Mendenhall will gain valuable experience working as a member of a multi-disciplinary team on recruitment, enrollment and participant engagement; quantitative and qualitative data collection and analysis and other activities related to the parent trial. An important part of Dr. Mendenhall’s experience will be to work on applying behavioral and implementation models and frameworks to enhance participation of underrepresented individuals in complementary and integrative health (CIH) research. Specifically, she will help develop, coordinate, and deploy creative recruitment strategies as specified in the Study Accrual and Retention Plan, and assist with critical qualitative data collection and analysis congruent with Aim 3. Dr. Mendenhall will also benefit from mentorship from Dr. Roni Evans (parent trial PI) who has successfully guided 20 mentees in CIH research. Finally, Dr. Mendenhall will further develop her skills through research coursework at the University of Minnesota and training at the YMCA’s Equity Leadership Institute. In summary, the Administrative Supplement will provide Dr. Mendenhall a comprehensive experience that is highly likely to facilitate her career development and lead to a commitment to a productive and independent career in community based CIH research that reaches all individuals for better health and wellbeing.

Public health relevance
PROJECT NARRATIVE This Administrative Supplement supports a second year of support for Heidi Mendenhall, a Doctor of Chiropractic. Renewal will build upon a productive first year, and continue to provide Dr. Mendenhall an immersive research experience in the parent clinical trial of mindfulness for physical activity in older adults conducted in collaboration with the YMCA. Aligned with the parent project aims, the supplemental aims will focus on applying behavioral and implementation models and frameworks to enhance participation of underrepresented individuals in complementary and integrative health (CIH) research.